Identifying Novel Signaling Mechanisms Downstream of Cardiac Gq-Coupled Receptors

Project Summary
N/A – this section is not applicable.

Public health relevance
Project Narrative N/A – this section is not applicable.